Administrative Core

The overall goal of the MD Anderson Cancer Center SPORE in Ovarian Cancer is to translate high-quality research into improved clinical outcomes for women with ovarian cancer. To ensure the success of the SPORE, the Administrative Core will provide effective management and administration of all activities relating to each project, core, career enhancement and developmental program in the SPORE. The Administrative Core will communicate and disseminate information between our SPORE investigators and facilitate information sharing and collaborations with other SPOREs and external collaborators. The Core will provide a platform for integrating multiple scientific disciplines into a unified multidisciplinary approach for achieving excellence in translational ovarian cancer research. The Administrative Core will monitor timelines and ensure both basic science and clinical trial aims are met for all SPORE projects. Co-Core Directors and MPIs, Drs. Anil Sood and Robert Bast, along with Ovarian SPORE Administrator, Ms. Estella Estrada, will direct the objectives of the Administrative Core. The objectives of the Core are to: 1) direct the planning and evaluation to ensure the overall scientific quality and strategic direction of the SPORE; 2) manage all fiscal and budgetary issues across all Projects, Cores and Developmental Research and Career Enhancement Programs; 3) monitor the data sharing compliance of the SPORE to adhere to all general governmental and specific NCI regulations and requirements; 4) coordinate quality assurance activities, including data quality controls with support from the Bioinformatics and Biostatistics Core and the Pathology Core; 5) serve as the communication hub for the SPORE to provide up-to-date operating information to investigators; 6) communicate and confer with the NCI Project Officer and other staff to make certain all necessary reporting requirements are met, including PMCID policy compliance; 7) coordinate the annual process for selection of Developmental Research and Career Enhancement Program recipients, and establish policies and procedures that result in the successful recruitment of highly qualified participants to these programs and ensure awardees are supported with outstanding mentorship; 8) ensure the SPORE is integrated in administrative organization of the institution; 9) initiate and coordinate inter-SPORE and inter-institutional interactions and seminars; 10) facilitate resolution of scientific disputes; and 11) organize and maintain patient advocate involvement in the SPORE.